Brains Minds and Machine Advanced Research Training Course

Project Summary
The question of intelligence—how the brain produces intelligent behavior and how to endow machines with
human-like capabilities—represents one of the greatest challenges in science and technology. Solving this
problem requires a deep understanding of how natural intelligence emerges, with computational rigor sufficient
to reproduce similar intelligent behavior in machines. Success in this endeavor will not only enhance our
understanding of ourselves but also enable the development of machines with human-like intelligence and
potentially even make humans smarter.
While today’s AI technologies are impressive, they differ fundamentally from human intelligence. We still lack a
clear understanding of the mechanisms underlying the robustness, generalization, and continual learning
capabilities of biological intelligence. A synergistic integration of neuroscience, cognitive science, engineering,
mathematics, and computer science holds the potential to unlock significant progress. By elucidating how
human intelligence works, we can develop more sophisticated and biologically inspired AI algorithms.
This in-person course aims to cultivate a community of leaders with a deep understanding of neuroscience,
cognitive science, and computer science. These individuals will be well-positioned to advance the scientific
understanding of intelligence, contribute to the creation of truly biologically inspired AI, and use this knowledge
to build computational tools to address brain disorders.
Throughout the course, students will engage in tutorials to gain hands-on experience in these topics. Core
presentations will be delivered collaboratively by experts in neuroscience, cognitive science, and computer
science. Lectures will be followed by afternoon computational labs and evening research seminars.
A central component of the course will be research projects guided by faculty and TAs. Many of these projects
may evolve beyond the course, leading to publications in scientific journals.

Public health relevance
Project Narrative The goal of this course is to establish a new field at the intersection of Artificial Intelligence (AI), neuroscience, and cognitive science. We will train a new generation of scholars who can fluidly understand and push the frontiers of multidisciplinary science, using cutting-edge AI as mechanistic models of brain function and using knowledge of biological neural circuits to build better AI algorithms. This knowledge will be imparted through discussions, tutorials, lectures, and especially through hands-on research projects.